Administrative Supplement: Borrelia gene products critical for natural infection cycle

PROJECT SUMMARY/ABSTRACT
Lyme disease is the most prevalent tick-borne infection in many parts of the world, including the U.S., where
over 450,000 new cases occur annually. The disease is inflicted by a group of bacterial pathogens, Borrelia
burgdorferi sensu lato, that thrive in nature through a complex enzootic infection cycle involving Ixodes
scapularis ticks and a variety of vertebrate hosts. Despite much effort, the infection remains difficult to control,
largely due to the absence of preventive strategies including vaccines, difficulties in the diagnosis of early
infection, and failure to achieve complete cures using current antibiotics. Specifically, several months after
standard-care antibiotic therapy, a subset of patients can experience a series of persistent or relapsing
symptoms, which are termed as chronic Lyme disease or post-treatment Lyme disease syndrome (PTLDS).
While the persistence of the bacterial infection may or may not contribute to the etiology or pathogenesis of
PTLDS, its treatment options remain unknown. Therefore, the development of vaccines and new drugs is
highly warranted. We have identified a critical virulence determinant called BbHtrA that plays an indispensable
role in host infectivity and persistence of spirochetes. Deletion of the protein renders the pathogen non-
infectious in mammalian hosts. Based on this information, we propose a therapeutics strategy that relies on
disruption of the protein function by small molecule drugs. To this end, we will identify small molecules that
disrupt BbHtrA protease activity by employing an assay designed for high-throughput screening (HTS) of large
compound libraries based on nanoDSF and fluorescence protease inhibition technology. Hits of this screen
will be validated by a secondary cellular assay, revealing potent compounds that are permeable across the B.
burgdorferi membrane. Compound screening will be performed in collaboration with National Center for
Advancing Translational Sciences (NCATS) investigators, who provide expertise, infrastructure, and modern
compound libraries, and have extensive experience with HTS and drug discovery. We will also attempt to
develop structural studies on BbHtrA, which will be important for the development of new therapeutic agents
targeting the protein. The validation of selected hit molecules in a whole animal model of Lyme disease will be
examined in future larger grant applications. The project employs cutting-edge technology that targets
interacting virulence determinants to combat Lyme disease, a novel strategy that may avoid PTLDS.
Moreover, the same approach may serve as a paradigm for combating other tick-borne infections, including
those caused by the recently-discovered, more virulent strains of Lyme disease pathogens.

Public health relevance
PROJECT NARRATIVE The treatment of Lyme disease remains a challenge because of the lack of human vaccines and frequent chronic symptoms following standard-care antibiotics. This project will develop new drugs based on a novel strategy targeting unique protein functions that the pathogen employs for infectivity and persistence in the mammalian host.